The C. elegans Germline: A Test Tube for Cell and Developmental Biology

Summary
The earliest stages of embryonic development are guided by mRNAs, proteins, and organelles provided by the
maternal germline. As the embryo switches from maternal to zygotic control, mechanisms are deployed to clear
maternal mRNAs from the embryo after they have completed their functions. The molecular mechanisms of
maternal mRNA clearance are incompletely understood but are of intensive interest for the field. We recently
discovered that a highly conserved RNA-binding protein is required for maternal mRNA clearance in the
nematode Caenorhabditis elegans. Remarkably, we found many mRNAs that are associated with this protein
(SPN-4) in oocytes are rapidly destabilized and cleared after fertilization. We are testing the hypothesis that
SPN-4 clears many of its associated mRNAs in somatic blastomeres through its association with the CCR4-NOT
deadenylase, which functions in mRNA destabilization. Mentoring the next generation of scientists has been a
central component and benefit of NIH’s longstanding support for this R35 award and its predecessor R01. During
the course of this research program, the PI has mentored scientists at every level—from undergraduate students
to faculty. The C. elegans molecular system provides an ideal format for training young scientists to conduct
hypothesis-driven research. The generation time is 3.5 days at 20°C. The worms are transparent and germ cells,
gametes, and embryos can be directly observed, as can the process of oocyte development, meiotic maturation,
and fertilization. The complete genome sequence and a well-annotated database facilitates molecular analysis.
Methods for CRISPR-Cas9 genome editing are robust and are routinely conducted by undergraduate students
in our laboratory. The evolutionary conservation of many developmental control genes ensures the wide
relevance of our findings to human biology. This effort has had substantial benefits for the effectiveness this
funded research program, as well as for more broadly contributing to the scientific workforce. This administrative
supplement to the parent award seeks to mentor an undergraduate student, who has been working in the PI’s
laboratory and who is committed to a career in biomedical research. This training will position her well for applying
to graduate school to pursue a PhD degree upon completion of her undergraduate degree program.

Public health relevance
NARRATIVE Defects in gametogenesis represent a major cause of human birth defects, miscarriage and infertility. Because ethical and technical issues limit the mechanistic depth of data obtained from human studies, model systems are invaluable. This application will delineate essential conserved mechanisms by which intercellular signaling and translational regulation regulate developmental programs needed for reproduction in the nematode Caenorhabditis elegans.